Probing the role of feature dimension maps in visual cognition

PROJECT SUMMARY
When looking for a red ladybug in a bush, our attention may be efficiently guided by the red color among the
green leaves. If, instead, finding a green caterpillar is our goal, the same red color would need to be ignored,
and instead a moving leaf should guide our search. Searching for an object involves a complex interplay between
features of the environment that are unique and capture our attention (e.g., the ladybug) and our current task
goals (e.g., look for the movement associated with a green caterpillar). It remains unknown how different brain
regions contribute to the guidance of visual attention based on different types of features of the environment,
and how activation patterns in these brain regions are impacted by our behavioral goals. Our long-term goal is
to understand the principles governing how distributed neural processing systems support flexible visual
cognition. Our overall objective, which is the next step in pursuit of our long-term goal, is to ascertain how top-
down goals and bottom-up stimulus properties jointly mold activation patterns across feature-selective brain
regions. Our central hypothesis is that the core computations supporting attentional selection – bottom-up
enhancement of salient locations and top-down enhancement of relevant locations or stimulus dimensions –
occur at the level of compartmentalized dimension maps instantiated in feature-selective cortical areas, and
these modulations are aggregated into a unified priority map to guide behavior. The rationale for the proposed
research is that, once we establish how attentional selection modulates dimension maps in healthy participants,
we can build improved diagnostic and therapeutic techniques to understand and treat disorders of attentional
control. This hypothesis will be tested across 3 Aims: (1) assay how bottom-up stimulus salience impacts
stimulus representations in dimension maps and priority maps; (2) characterize the independent impact of top-
down attentional selection on activation profiles within dimension maps, and (3) establish the role of neural
dimension maps in guiding attention during visual search tasks. Across all Aims, we will apply model-based
neuroimaging analyses to assay stimulus representations in feature-selective retinotopic brain regions measured
with fMRI. In Aim 1, participants will perform a fixation task while we present different types of stimuli to measure
responses associated with stimulus salience in different features. In Aim 2, participants will selectively attend to
one of several feature values defining a stimulus while we manipulate properties of the stimulus display. In Aim
3, participants will perform a demanding visual search task while we manipulate aspects of the task and stimulus
display. Overall, this project will generate data to determine the role of dimension maps in guiding visual attention.
This project is innovative because it uses model-based neuroimaging analyses to characterize spatial maps
carried by feature-selective brain regions during demanding cognitive behavior, and because it tests a key aspect
of an important theoretical framework. This project is significant because it will lead to a new understanding of
how disparate brain regions collaborate to incorporate stimulus- and task-related factors to guide visual attention.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because improved understanding of the neural mechanisms supporting visual attention in the healthy human brain is a key step towards identifying possible ways the system can fail. This basic understanding is expected to lead to new theoretical frameworks from which novel diagnostic and therapeutic techniques will emerge. Individuals with Schizophrenia and those with anxiety can present with impairments in the functioning of visual attention, so identifying the neural processes supporting this cognitive ability in healthy individuals will be relevant for understanding the etiology of these and other neurological and psychiatric disorders.